PET Tracer for Imaging of Lung Inflammation

Abstract. Lung transplantation is a well-established surgical intervention in advanced stages of the
disease in pulmonary medicine. Despite improvements in surgical procedures and
immunosuppressive therapeutic paradigms, the median survival rate continues to be 6 years.
Literature precedents show that chronic lung allograft dysfunction (CLAD) is the most significant barrier
to long-term survival of lung transplantation. However, prediction and early diagnosis of CLAD using
current techniques continues to be problematic due to lower sensitivity (HRCT) and specificity
(circulating biomarkers). Currently, the reference standard to detect acute rejection is a
histopathological grading of transbronchial biopsies (TBBs), however, it is an invasive technique with
several limitations (bleeding, inconsistent outcomes, inherent risks associated with repetitive
procedures) including detection at advanced stages of the disease. Therefore, agents capable of
offering non-invasive assessment of chronic rejection after transplantation are a highly desirable
diagnostic nuclear medicine resource, yet continues to be an unmet need. To accomplish this
objective, we have developed a new PET tracer (named as 68Ga-Galuminox), which offers noninvasive
assessment of acute lung injury, and also demonstrates promising higher uptake in alveolar
macrophages of mouse ex vivo lung transplant model of CLAD, and human lung recipients with a
CLAD diagnosis compared to CLAD free subjects. Finally, preliminary 68Ga-Galuminox preclinical
PET imaging in our mouse CLAD model has revealed (at 30 min post tail-vein injection) 2-fold higher
retention in the left transplanted lung with early signs of CLAD when compared to the non-diseased
(untransplanted) right lung. Notably, these observations are also consistent with the observed
activation of macrophages and PMNs in CLAD lungs as measured by flow cytometry that identifies
single cell Galuminox uptake by detecting its native fluorescence. Armed with this supporting
information, aims of our preclinical translational RO1 are: Aim 1: Aim 1: Perform radiation dosimetry
to determine human effective dose equivalent (HED), toxicology studies, and GMP validation runs for
Galuminox to prepare for an IND filing; Aim 2: Perform first-in-human studies using 68Ga-Galuminox:
evaluate dosimetry, biodistribution, safety, and imaging characteristics following a single injection at rest
(n=8, 4 males; 4 females); and Aim 3: To evaluate performance of 68Ga-Galuminox and 18F-FDG for
detection of CLAD pathogenesis in a mouse model of lung transplantation; Aim 3.1: To determine if
68Ga-Galuminox can detect early and late CLAD pathogenesis; Aim 3.2: To determine if 68Ga-
Galuminox can be used to evaluate responses to CLAD treatment; and Aim 3.3: Biochemically
characterize mechanism(s) of location of the 68Ga-Galuminox through cell accumulation, sub-cellular
fractionation studies, pharmacokinetics, and LPS-induced inflammation either in presence or absence
of mitoTempo (MTT) and Dexrazoxane (DEX) in rodents to assess its ability to serve as noninvasive
molecular imaging agent for monitoring lung injury. Successful accomplishment of proposed aims
could enable: a) deployment of a noninvasive redox-sensitive reporter probe as a diagnostic tool for
stratification of patients with a risk factor for CLAD; b) potentially new interventional opportunities; c)
enabling longitudinal studies of disease pathology; and d) monitoring therapeutic efficacy of drugs.
Combined factors could significantly advance management of CLAD patients with potential detection
of CLAD at earliest stages.

Public health relevance
Project Narrative. Lung transplantation is a well-established surgical intervention in advanced stages of the disease. Despite improvements in surgical procedures and immunosuppressive therapeutics, the median survival rate of the transplanted lung continues to be approx. 6 years. Chronic rejection of the transplanted lung is the most important obstacle to its long-term survival. Current state of-the-art reference technique for detecting chronic rejection is histopathological grading of transbronchial biopsies (TBBs). However, this is a highly invasive technique with several limitations, such as bleeding, inconsistent outcomes, and detection at advanced stages of the disease. Therefore, molecular imaging agent capable of allowing non-invasive assessment of chronic rejection after transplantation is a highly desirable diagnostic tool in nuclear medicine yet continues to be an unmet need. To accomplish this objective, this project is focused upon advancing the lead PET tracer further from preclinical development phase to prepare data for regulatory approvals and simultaneously assess its potential to image chronic rejection of the transplanted lung in mouse models at earlier stages. Of note, this project builds on pilot promising data with the new probe in mouse lung transplant model and human specimens. It is anticipated that successful accomplishment of proposed aims could deliver data for translation of a new PET molecular imaging agent for assessment of acute lung injury through first human studies, and a versatile noninvasive tool for stratification of patients with a risk factor for developing chronic lung allograft dysfunction thus nudging lung transplantation landscape towards image-guided pulmonary medicine.